Integrated Clinical-Grade genomic and pathology AI biomarkers for high-risk prostate cancer

Project Summary
Each year 375,000 men die of prostate cancer, the majority having received an initial diagnosis of high-risk
disease. The combination of radiation therapy (RT) and androgen deprivation therapy (ADT) have been the
standard treatment for decades, but recently a phase III trial demonstrated that the addition of newer androgen
receptor signaling inhibitors (ARSIs) to the standard therapy significantly improved metastasis-free survival.
However, high cost and increased grade 3 toxicities with the addition of ARSIs suggests a need for more careful
patient selection to maximize treatment efficacy while minimizing therapy side effects and reducing cost. This
team has previously performed key studies validating the Decipher genomic classifier and the Artera artificial
intelligence (AI)-based digital pathology tools as risk stratification approaches for patients with localized prostate
cancer. This resulted in the designation of Level 1 (the strongest level of evidence) supporting the use of these
classifiers in the 2023 NCCN Guidelines for Prostate Cancer Management and the use of these two classifiers
independent of each other in the clinic. However, it is still unknown how they compare to each other, particularly
in identifying patients who would benefit from the addition of ARSI to RT and standard ADT and whether
integrating genomic and pathology AI classifiers can result in improved performance compared to each individual
approach. This application will address these unmet needs by: 1) Validating genomic and pathology AI as
prognostic biomarkers for high-risk prostate cancer patients; 2) Validating genomic and pathology AI as
predictive biomarkers for the addition of ARSIs to RT + ADT; and 3) Developing and validating integrated
genomic and pathology AI prognostic biomarkers and predictors of response to the addition of ARSI to RT +
ADT. With access to pretreatment tissue samples from four international phase III trials (STAMPEDE,
ENZARAD, ATLAS, and PREDICT-RT) and both the Artera AI and Decipher Genomic Classifier tools, this
application is uniquely positioned to develop impactful and cost-effective prognostic and predictive clinical-grade
biomarkers for management of men with high-risk prostate cancer. The CLIA-compliant platforms enable rapid
clinical translation of biomarkers to personalize therapy and thus reduce cost and avoid harmful side effects
among patients who might not benefit from addition of ARSI, thus providing a paradigm shift in prostate cancer
treatment.

Public health relevance
Project Narrative Of the over 1.4 million new patients diagnosed with prostate cancer each year, 375,000 die despite aggressive combination radiotherapy and androgen deprivation therapy, with little change in this therapy regime over the last decade. Promisingly, recent results of a phase III clinical trial demonstrated that when androgen receptor signaling inhibitors were added to radiotherapy and androgen deprivation therapy, patients saw significantly longer metastasis-free survival, but androgen receptor signaling inhibitors come with higher risks of side effects and can be very costly. To bring together the power of AI and the advanced understanding of prostate cancer genomics, we aim to develop both Decipher genomic testing and Artera AI-based digital pathology to identify which patients will benefit from addition of androgen receptor signaling inhibitors to enable personalized therapy selection that avoids harmful side effects.